Impact of DNA double-strand breaks on 3D genome organization and genome stability in Alzheimer's disease

PROJECT SUMMARY/ABSTRACT
The accumulation of DNA Double-Strand Breaks (DSBs) in neurons is an early hallmark of Alzheimer’s disease
(AD). Increased DSBs are also associated with aging, which is the largest risk factor for AD. AD is also a complex
disease involving all major brain glial cell types. Thus, there is a critical need to understand the molecular
mechanisms of DSB induced changes in both neurons and glia. The structural stability of the genome is
paramount in maintaining a functional genome, and recently, the 3D organization of the genome has emerged
as a major regulator of genome function. My overall hypothesis is that 3D genome reorganization and structural
genome instability mediated by DSBs are principle drivers of AD pathogenesis and brain aging. My objective is
to determine how and to what extent DSBs within the neurons impact genome organization and the glial
response, with the goal of identifying molecular pathways that can be targeted as novel therapies for preventing
or halting the progression of neurodegeneration. I will use mouse models that recapitulate the pre-symptomatic
accumulation of DSBs in neurons and human iPSC models to determine the degree of the 3D genome disruption
caused due to DSBs and the underlying molecular mechanisms. I will also identify the consequences of neuronal
DSBs on the structural stability of the genome by measuring the frequency of DSB mediated chromosomal
translocations in human AD neurons. Interestingly, normal neuronal activity causes DSBs at immediate early
gene promoters. Also, neuronal hyperactivity has been reported in AD. I will test if IEGs are locations of frequent
chromosomal translocations after neuronal hyperactivity induced in neuronal culture.
Previous studies have shown that microglia transitions to a reactive state in response to
neurodegeneration. To understand the role of the 3D genome organization in this microglia transition, I will use
single cell Hi-C to measure the unique chromatin interactions that mediate the reactive microglia state.
Subsequently, transcription factor predictions using integrative analysis of single cell Hi-C will be tested in iPSC
derived microglia-neuron co-cultures for their potential to modulate the reactive microglia response. This
approach will be extended to study oligodendrocyte response in the independent phase.
I will work with my mentor Dr. Li-Huei Tsai, my mentorship committee, Dr. Bruce Yankner and Dr. Manolis
Kellis, my technical support and advisory committee, Dr. Frederick Alt and Dr. Peter Fraser to carry out my
proposed training plan. I will gain experience in iPSC technology and differentiation from the Tsai lab to modulate
the disease associated microglia response to neuronal DSBs and work with Dr. Manolis Kellis to implement the
computational pipelines for the transcription factor predictions. To bridge the gap in my training in the biology of
AD and brain aging, I will audit relevant courses and receive additional mentoring from Dr. Bruce Yankner.

Public health relevance
PROJECT NARRATIVE Although, increased DNA breaks within the genome are associated with Alzheimer’s disease and brain aging, the molecular mechanisms of this association remain unclear. I propose to use cutting-edge tools to measure the impact of DNA breaks on genome organization to understand the mechanisms of how DNA breaks lead to Alzheimer’s disease, and test the therapeutic potential of these pathways. The proposal is relevant to public health and the mission of the NIA because it improves our fundamental understanding about the biology of Alzheimer's disease with the goal of developing therapeutic interventions.